GI262570 sodium tablets monotherapy for 26wks in NIDDM

To compare the effects of oral GI262570 with that of placebo on glycemic control(as measured by HbA1c) after 26 weeks in the treatment of Type 2 DM.